Repurposing Endonuclease V for the detection and engineering of adenosine-to-inosine editing

Project Summary/Abstract
RNA editing is a widespread strategy employed by cells to post-transcriptionally alter protein sequence and gene
expression levels. Adenosine-to-inosine (A-to-I) editing is among the most common and impactful of these RNA
modifications and is catalyzed by adenosine deaminases acting on RNA (ADARs). Deamination changes the
structure and hydrogen bonding pattern of the nucleobase, and resulting inosines hybridize with cytosine to
effectively recode these sites as guanine. Editing is essential for a number of processes including embryogene-
sis, neurological function, and innate cellular immunity, and dysfunctional editing is also linked to autoimmune
diseases, neurological disorders, and several types of cancer. Despite the critical role of A-to-I editing in cellular
function, our understanding of the locations and frequency of this modification are confined by the inherent limi-
tations in the currently available methods for mapping and quantifying inosine in the transcriptome. Additionally,
the ability to site-selectively induce A-to-I editing would be extremely valuable for both the study of this modifi-
cation and the development of new therapeutic approaches, yet current methods are hampered by their reliance
on the substrate binding preferences of native or modified ADAR enzymes. A central challenge that has hindered
the development of methods for studying A-to-I editing is the lack of availability of anti-inosine antibodies or other
affinity reagents capable of selective binding to this modified nucleotide. We have overcome this challenge by
repurposing the naturally occurring EndoV protein from an RNA-cleaving enzyme into an RNA-binding protein
and have used this to develop a workflow to enrich inosine-containing RNAs from total cellular RNA. We have
shown that this increases the fraction of reads in RNA-seq data that contain inosine and facilitates the discovery
of new A-to-I editing sites in the transcriptome. The proposed research will leverage our EndoV method to de-
velop a toolbox of technologies to advance the study and engineering of A-to-I editing. Together, these new
methods will enable researchers to more accurately map editing sites in the transcriptome, quantify changes in
overall editing prevalence rapidly and in high-throughput, and direct editing at specific target sites in living cells.
Additionally, the methods developed here can be applied to other epitranscriptomic modifications beyond ino-
sine, providing a set of technologies that are of broad utility to the RNA editing community.

Public health relevance
Project Narrative RNA editing plays a key role in cellular functions including development, stem cell differentiation, and immune response, and is frequently dysregulated in disease. This research will develop a suite of tech- nologies to study and control editing, which will aid in the development of new diagnostic and therapeutic approaches.